CLINICAL TRIAL: EFFECTS OF COENZYME Q10 IN PARKINSON DISEASE (QE#)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a 16-month study to asses the effects of creatine (two doses) versus placebo on slowing the progressive impairment of Parkinson's disease in early untreated patients.